The Health and Education Impacts of Long-Run Exposure to Pollution in Childhood: Evidence from the US Army

The Health and Educational Impacts from Long-Run Exposure to Pollution in Childhood:
Evidence from the US Army (30 lines)
A large body of research documents that childhood circumstances have significant long-term
effects on individuals' lifetime outcomes (Almond et al. 2018). We aim to assess the causal
effect of long-term air pollution exposure throughout childhood on the health and education of
children and young adults. We specifically focus on the pollutant fine particulate matter (PM2.5),
which has detrimental effects on the body because it penetrates deep into the lungs and crosses
over to the bloodstream. There are many studies that suggest that long term PM2.5 exposure is
associated with harm to both health and cognition. However, because children exposed to higher
levels of air pollution for many years are more likely to come from families of lower socio-economic
status, which also impacts health and cognition directly, these studies cannot establish causal
effects from PM2.5 exposure over many years.
To estimate the causal impacts of long-run pollution exposure, we focus on military children. This
focus on the military is important, as previous studies suggest that pollution exposure in military
families is determined by the needs of the military rather than the preferences of the soldier,
making it independent from the health or socio-economic status of those exposed. Using military
personnel records, we will construct a large sample of children followed for up to 20 years. These
data will be matched to pollution using state-of-the art satellite-based data. Using administrative
data from health insurance claims and education records, we will investigate the impacts of long
term PM2.5 exposure on a range of health and education outcomes.

Public health relevance
Project narrative – relevance (2-3 sentences) In this project, we aim to assess the causal effects of long-term pollution exposure on children's health and educational attainment. We will focus on the children of military personnel, who represent an ideal group for this study because of rich administrative data that allows us to track the location and health status of children from birth to young adulthood. Our results will contribute to a greater understanding of how the environment that children grow up in affects their long-term health and socioeconomic status, as well as provide guidance for regulatory policy on what constitutes safe levels of pollution exposure for this vulnerable subpopulation.